Hippo and Wnt Signaling in Cardiac Regeneration

This R01 application will investigate a novel signaling pathway, the Hippo pathway, in
mammalian heart regeneration. The long-term goal is to develop new treatments for
patients with heart failure by generating new cardiomyocytes in the adult heart. The
objectives of this application are to gain insight into molecular properties of cardiac
tissue that are regulated by Hippo signaling. The central hypothesis is that Hippo
signaling is a negative regulatory pathway that prevents cardiomyocyte regeneration in
the adult mammalian heart. The specific aims are to determine whether the Hippo and
Wnt pathways regulate adult heart repair in a manner similar to the interaction in
neonatal hearts. To determine whether an autonomous Wnt Hippo interaction occurs in
heart muscle nuclei to control important genes and to investigate whether Hippo
functions in a reversible manner. The project is conceptually and technically innovative.
Concepts to be tested include new ideas in cardiomyocyte biology and cutting edge
genome editing and interrogation technologies to address hypotheses. The significance
is high because there are no treatments for heart failure due to cardiomyocyte loss.
Devising ways to generate new cardiomyocytes is highly significant.

Public health relevance
Heart failure due to cardiomyocyte loss and pump dysfunction after ischemic heart disease is the leading cause of death in the United States. We strive to facilitate cardiac regeneration after heart damage to improve survival rates. Limited endogenous adult cardiomyocyte regenerative potential after acute damage results from inadequate adult cardiomyocyte proliferative capacity. Our goal is to devise new methods to promote heart repair.